ISO-BCC STUDY COORDINATING CENTER

The Cancer Prevention Studies Branch is conducting a study to determine if Isotretinoin will prevent Basal Cell Carcinoma. This project will provide data support and act as the data coordinating center for this study.